Individual Breastfeeding Support with Contingent Incentives for Low-Income Mothers

PROJECT SUMMARY/ABSTRACT
In this R01 application we propose to examine the efficacy of monthly financial incentives contingent on
observed breastfeeding (BF), supplemental to existing support from the Special Supplemental Nutrition
Program for Women, Infants, and Children (WIC) program and home-based individual BF support, among low-
income mothers. Low-income racial/ethnic-minority women breastfeed for an average duration of four months
despite evidence-based recommendations by the American Academy of Pediatrics to exclusively breastfeed
for six months of life in addition to continued breastfeeding through the first year. Insufficient duration of any BF
is related to multiple maternal and child health problems, and increases in BF duration could be cost saving
medically and societally. Though peer support has been effective in prolonging BF duration, the effect has not
been as strong for WIC-eligible, low-income mothers. An incentive-based intervention was tested among low-
income Puerto Rican mothers in a pilot study (R03HD077057) resulting in promising outcomes of monthly
financial incentives contingent on observed BF for 6 months combined with WIC BF usual care, compared to
WIC BF usual care only (BF rates: 89% vs. 44% at 1-month; p = 0.01; 89% vs. 17% at 3-month; p<0.01; 72%
vs. 0% at 6-month; p<0.01; N = 36). We propose a 2-group parallel randomized controlled trial in which half of
the 168 WIC-eligible mothers will be allocated into each of the two study groups: (1) Standard Care BF Support
(WIC support + home-based individual support; Standard Care (SC)) and (2) Incentives contingent on
demonstrating successful BF (SC + Breastfeeding Incentives; SC+BFI). Participants randomized into SC will
receive standard breastfeeding services from WIC and home visitations for individual support and problem-
solving. Participants randomized into SC+BFI will receive the same services as Control except that monthly
financial incentives are contingent on observed BF and delivered at the end of each month. The study will be
conducted in two regional sites with high concentrations of low-income racial/ethnic minority mothers,
Philadelphia, PA and Wilmington, DE. The primary outcome will be the BF rate for 6-month postpartum, the
exploratory outcome will be the BF rate at 12-month postpartum, and the secondary outcomes will be infant
outcomes (i.e., weight gain and emergency room visits). We hypothesize that SC+BFI will increase the BF rate
by 25% at 6-month postpartum and have significantly lower infant weight gain and incidents of ER visits for
infants at 3-month postpartum, compared to SC. We will track the costs of intervention, formula purchased by
mothers, and infant medical care in both groups. We will also conduct interviews with corporate
representatives and insurance companies to explore community- and policy-level support to sustain the
incentive-based intervention for WIC mothers. The aims of the proposal are guided by the mission of NICHD's
Pregnancy and Perinatology Branch to improve the long-term maternal and infant health of low-income
populations via encouraging breastfeeding in the translational research context.

Public health relevance
PROJECT NARRATIVE The proposed study of examining the efficacy of monthly financial incentives contingent on observed breastfeeding, supplemental to existing breastfeeding support from the Special Supplemental Nutrition Program for Women, Infants, and Children (WIC) as well as home-based individual support, to increase breastfeeding duration among low-income mothers is relevant to public health for 4 reasons: (1) the proposed research addresses Healthy People 2020 goals in maternal and child health and breastfeeding duration (MICH-21); (2) the proposed research addresses health disparities related to insufficient durations of breastfeeding among socioeconomically-disadvantaged mothers in the US; (3) insufficient breastfeeding duration is related to maternal health issues and pediatric mortality, obesity, and infectious diseases; and (4) if breastfeeding duration were increased to meet the Healthy People 2020 goals, it would save the US over $16 billion annually from reduced direct and indirect medical and societal costs.